Research Training Program in Reproductive and Sexual Health

PROJECT SUMMARY
The vision of The ASCENT Research Training Program in Sexual and Reproductive Health, Rights, and
Justice (SRHRJ) is to strategically develop an innovative, interdisciplinary, multi-level national research
training experience to increase diverse representation and to enhance the future of SRHRJ-related biomedical,
behavioral, policy, clinical, and translational research. The program will do this through foundational research
curricula, advanced training in community-engaged research (CER), hands-on simulation training, and mini-
immersion experiences, and mentoring, using the Matrix Mentor Model. Currently, research curricula and
mentorship specific to SRHRJ and CER are lacking in consistency and accessibility across academic
institutions, disciplines, and training levels. The stigma and politicization surrounding SRHRJ have created
barriers to comprehensive education, research, and innovation in this crucial field. Strategic efforts are
necessary to progress academic and community partnerships that can lead to critical innovations and
interventions through CER. To address this gap, we have designed a unique research training program with
community-, institutional-, and national support open to Scholars from upper undergraduate to professional
levels. The program goals include, (1) Establishing The ASCENT Research Training Program, creating
administrative excellence and a research training toolkit focused on advanced SRHRJ topics and CER
methods, (2) Providing 10 weeks of focused hands-on research experiences, mentoring, and funding for a
diverse cohort of 8 nationally recruited SRHRJ Scholars; and (3) Develop regional and national opportunities
for scholar advancement through partnerships with the Scholars Strategy Network and the Society for Family
Planning. These national partners will support recruitment and provide a diverse pool of mentors and research
opportunities showcasing specialized research techniques. ASCENT Research Training Program Scholars will
gain SRHRJ knowledge, confidence, and essential hands-on CER experience. The program will support
Scholars in attending and presenting at regional and national scientific conferences to enhance their
professional networks and career trajectories. Successful completion of these activities will establish a multi-
level interdisciplinary SRHRJ Scholar training program, unlike any existing program. Ultimately, this program
and toolkit will increase accessibility to advanced CER techniques, enhance the training experiences of
SRHRJ biomedical scholars, and train a new generation of diverse reproductive health scholars trained in CER
and advanced research approaches.

Public health relevance
PROJECT NARRATIVE Currently, research curricula and mentorship specific to Sexual and Reproductive Health, Rights and Justice (SRHRJ) topics, and Community-Engaged Research (CER) methods are lacking in consistency and accessibility across academic institutions, disciplines, and training levels. The University of Utah-based ASCENT Center for Reproductive Health is poised to address this through the creation of the ASCENT Research Training Program SRHRJ open to scholars nationwide from upper undergraduates to professional level. Ultimately, this program and resulting toolkit will increase accessibility to advanced CER techniques, enhance the training experience, and support professional and career development for a new generation of diverse SRHRJ scholars.